Testing Peer-led Network Intervention to Prevent Adolescent Vaping

ABSTRACT
Rates of adolescent vaping are increasing rapidly. Current high school student use of electronic vaping
products (EVPs) rose from 1.5% in 2011 to 20.8% in 2018 – an increase from 220,000 to 3.05 million
adolescent users. Vaping is associated with respiratory symptoms, and exposure to nicotine can act as a
`gateway' to other drug use. Effective, school-based interventions are urgently needed to protect adolescents
from initiating or continuing use of EVPs. A recent US Surgeon General's report identified no school or
community based prevention program that reduces vaping behaviors among youth. This proposal takes
advantage of a state-supported prevention initiative to test the efficacy of Above the Influence of Vaping (ATI-
V). ATI-V trains peer nominated 8th-9th grade Peer Leader, and adult advisors. Peer Leaders learn skills and
implement school-wide prevention campaigns informed by communication science. Preliminary data show
that after training approximately 15% of 8th graders as Peer Leaders, who implemented school-wide campaigns,
students who were friends of Peer leader had reduced vaping intentions and vaping behaviors 2nd semester of
8th grade. New York State has provided funds to support schools to implement ATI-V but no funds for efficacy
research. With support from New York State and a strong team of investigators, our project has three aims:
Aim 1. Efficacy. The primary aim of this study is to determine ATI-V impact in preventing vaping use (past
30 days any vaping, nicotine vaping, and regular use). Using an RCT design, 20 schools will be assigned to (a)
immediate ATI-V, or (b) wait-list for ATI-V training after 24 months. Approximately 3,800 8th graders will be
enrolled and followed for assessments in fall 8th grade, spring 8th grade, spring 9th grade, and mid-year 10th
grade. We will test for which students ATI-V is most effective and in what school contexts (school climate).
Aim 2. Mechanism. The second aim of this study to test the hypothesized mechanisms of ATI-V impact. To
accomplish this aim we will conduct statistical analyses of a mediation model to determine (a) whether ATI-V
improves students' perceptions that vaping is unacceptable to their peers (anti-vaping norms), connections to
supportive adults to address EVP concerns, and social influence of non-vaping students; and (b) whether the
impact of ATI-V on reduced vaping behavior is mediated by these improvements.
Aim 3. Implementation (Exploratory). Our exploratory aim is to identify implementation barriers and
facilitators by gathering qualitative data (observations, semi-structured interviews) from staff and students
from a subset of high and low implementing schools. The purpose is to identify what implementation
strategies and supports are needed for future schools to be successful in implementing ATI-V, if warranted by
the study findings. If study hypotheses are supported, this study will provide, to our knowledge, the first
evidence of a school-based prevention intervention that reduces adolescent vaping behaviors.

Public health relevance
PROJECT NARRATIVE Effective, school-based interventions are urgently needed to protect adolescents from initiating or continuing use of electronic vaping products (EVPs). This study leverages a state-supported prevention initiative to test the effectiveness of a promising intervention that trains 8th -9th grade student peer leaders to deliver school- wide vaping prevention campaigns with ongoing adult mentoring. If study hypotheses are supported, the study will provide the first evidence of a school-based preventive intervention that reduces adolescent vaping behaviors, as well as insight into how peer communications can be harnessed to prevent vaping.